Characterizing treatment responses for common lung cancer (LC) subtypes in Latinos and Asians

SPECIFIC AIMS
The purpose of UCaTS Project 2 is to target clinically important genomic markers of early resistance to EGFR
tyrosine kinase inhibitors (EGFR-TKIs) in EGFR-mutant non-small cell lung cancer (NSCLC), to develop
quantitative models of Receptor Tyrosine Kinase (RTK)-driven signaling pathways under inhibition, and to
explore the role race, ethnicity and genetic ancestry has in predicting baseline EGFR signaling and EGFR-TKI
treatment response. EGFR-mutant NSCLC comprises a substantial subset of lung adenocarcinoma (15% in
Western/White populations) and occurs with a higher frequency in Asian Americans, Native Hawaiians, Pacific
Islanders (AANHPI ~50%), and Latinos (~38%). EGFR mutations show strong associations with smoking status,
gender, race/ethnicity, and genetic ancestry. Women of AANHPI and Latino race/ethnicity have, compared to
non-Latino Whites (NLW), lower smoking rates and higher frequency of EGFR mutant tumors. Interestingly, a
recent study showed that high Indigenous American Ancestry (which is closely associated with Asian ancestry)
confers a higher risk of developing EGFR-mutant lung cancer in Latinos. This suggests that somatic EGFR
mutations have close associations of biological and non-biological aspects associated with race/ethnicity or
ancestry. Through this research, we will develop novel therapeutic strategies with combinations of FDA approved
and NCI-CTEP drugs to translate into NCI-sponsored clinical trials overcoming EGFR-TKI resistance
mechanisms associated in EGFR-mutant NSCLC. We will also assess whether race/ethnicity and genetic
ancestry impacts EGFR signaling and influences responses to EGFR inhibition.
Patient-derived xenografts (PDXs) have been broadly used in lung cancer research and drug development.
We have extensive experience in establishing PDXs and conducting PDX-based research. Through the Jackson
Laboratory (JAX), UCSF and UT Southwestern collaborations, we established and characterized over 200 lung
cancer PDXs in which 25 have EGFR-activating mutations and we have identified an additional 10 EGFR-mutant
lung cancer models in PDXnet. We anticipate that UCaTS will generate at least 25 additional EGFR-mutant
PDXs. We have performed detailed histopathological and genomic characterization on many of these PDXs
focused on oncogene driven NSCLC where we identified multiple putative resistance mechanisms that mediate
early resistance to current EGFR-targeted therapeutic approaches in these models. We have also shown that
EGFR-mutant PDXs can potentially be used to optimize treatment combinations to overcome EGFR-TKI
resistance and to identify the most efficacious drugs or drug combinations including FDA approved and NCI-
CTEP agents. We will use a high-content live-cell imaging platform to analyze intracellular EGFR signaling, which
provides a high-resolution assessment of cellular adaptation to inhibition. The work for this project arises out of
our current research, which will be used to address the following specific aims.:
Aim 1: Develop targeted treatment combinations with FDA approved drugs and/or NCI-CTEP agents to
overcome mechanisms of resistance to EGFR-TKIs that herald early tumor progression. We plan to a)
determine the most effective dual MET/EGFR targeting strategy in EGFR-mutant PDX models harboring MET-
mediated bypass tract mechanisms of EGFR-TKI resistance; b) determine the most effective dual EGFR-
blockade approach in EGFR-mutant PDXs harboring uncommon EGFR-mutations; and c) overcome the limited
apoptotic response in RBM10 deficient EGFR-mutant NSCLC with the BCL-2/BCL-xL inhibitor and NCI-CTEP
agent pelcitoclax.
Aim 2: Modeling EGFR inhibitor effects using signaling dynamics in live cells. The premise is that targeted
inhibitor therapy can be optimized by characterizing quantitative variation in RTK-driven intracellular signaling
across different EGFR mutants, genetic backgrounds, and inhibitor classes. We will use kinase activity
biosensors to track AKT and ERK activity patterns with single-cell resolution in the set of PDX models used in
Aim 1. This high-content analysis, in combination with the diverse set of EGFR mutations and genetic
backgrounds represented by the PDX panel, will provide the data for a quantitative model with an unprecedented
scope. Leveraging machine learning methods, our model will allow us to identify the primary signaling
parameters determining response to multiple classes (and combinations) of EGFR inhibitors, MET inhibitors,
and Bcl-2/Bcl-xL family inhibitors. Importantly, our model will help to answer a long-standing question of whether
EGFR inhibitor resistance involves a shared set of signaling determinants across individuals and backgrounds,
or instead depends on patient or genetic background-specific factors. Furthermore, when our results are
integrated with Aim 1, we will have the unique opportunity to validate our cellular model against in vivo data.
Aim 3: Examining the role of race/ethnicity and genetic ancestry in EGFR signaling and responses to
EGFR therapies. As our study will test EGFR therapies in large numbers of EGFR-mutant models from AANHPI,
Latinos, and NLW, we will evaluate whether baseline signaling and responses to the third generation EGFR-TKI
osimertinib are influenced by race/ethnicity. In Latinos, we will also estimate individual levels of Indigenous
American ancestry and will evaluate its associations with baseline signaling and treatment response.
IMPACT: This project will advance EGFR therapy and our understanding of EGFR signaling in lung cancer with
a focus on minorities, including information that will lead to a more equitable translation into clinical trials.

Public health relevance
PROJECT 2 NARRATIVE The University of California and University of Texas Southwestern Diversity Patient-Derived Xenograft (PDX) Development and Trial Center leverages the collective strengths of six NCI-Comprehensive Cancer Centers to create minority patient cancer models and characterize targeted treatment responses to lung tumors. This project focuses on the epidermal growth factor receptor (EGFR) mutation in non-small cell lung cancer, which is a tumor driving gene that occurs with a higher frequency in Asian Americans, Native Hawaiians, Pacific Islanders (AANHPI ~50%), and Latinos (~38%). Through UCaTS activities, we expect to extend our repository of minority PDXs focused on EGFR mutant lung cancer and to facilitate the discovery of new therapies that could impact vulnerable racial and ethnic minority cancer patients.